Residue-by-residue details of FUS protein phase separation and aggregation

Project Summary
RNA-binding proteins are essential components of numerous large complexes that carry out fundamental
processes including transcription, splicing, and DNA repair. Many RNA-binding proteins possess regions
predicted to be disordered based on low-complexity sequence characteristics that are critical to normal RNA-
processing functions, but also drive aberrant protein assembly in various neurodegenerative disease and
cancers. The molecular interactions and functional roles of these disordered domains remain incompletely
characterized, especially in the context of disease. Fused in Sarcoma (FUS) is one of twenty-nine human
RNA-binding proteins that contains both an essential disordered low-complexity domain (LC) with unusually
low charged residue composition and a high frequency of aromatic amino acids as well as several RGG motif
regions. Despite disorder, these domains are thought to facilitate interactions in normal RNA metabolism by
forming dynamic associations, thereby enabling tunable, reversible spatial clustering. Yet, excessive self-
association between FUS disordered domains is believed to result in the formation of pathological neuronal
inclusions in sub-types of amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD), irreversible
neurodegenerative diseases that lack effective treatments. Moreover, fusion of the FUS disordered domains to
several DNA-binding domains through chromosomal translocations results in uncontrolled gene expression
leading to a family of aggressive cancers. Though FUS has emerged as the primary model system for
understanding biological phase separation, the contacts holding together FUS assemblies and their structures
in physiology and disease are currently unknown because they are invisible to traditional techniques in
structural biology. However, we have demonstrated that we can visualize dynamic assemblies of FUS with
residue-level resolution. This project will apply advanced nuclear magnetic resonance spectroscopy, molecular
simulation, and cell models of FUS function to 1) visualize the molecular contacts that mediate LLPS and in-
cell interactions, 2) probe the molecular and cellular impact of LC and RGG mutations of FUS found in familial
ALS, and 3) determine the functionally relevant atomic details of FUS complexes with RNA and the C-terminal
domain (CTD) of RNA polymerase II associated with RNA processing and transcription. These studies of FUS
assembly will provide necessary structure/function information on future pharmacological targets for inhibiting
pathological protein associations in types of ALS, FTD, leukemia, and sarcoma. Furthermore, because FUS is
only one of many essential RNA-binding proteins containing aggregation-prone low complexity domains, the
results of the project will serve as a foundation for understanding an entire class of proteins and for correcting
their dysfunctions in disease.

Public health relevance
Project Narrative Unstructured domains of a family of RNA-binding proteins form aggregates implicated in amyotrophic lateral sclerosis (also known as ALS or Lou Gehrig’s Disease) and make up cancer-causing domains in forms of leukemia and sarcoma. Determining the structural details of the RNA-binding protein Fused in Sarcoma and its assemblies is the first step to finding new therapies to prevent these difficult-to-treat diseases.